Short Term Training in Health Professional Schools

Short Term Training in Health Professional Schools
The long-term objectives of the proposed short-term training program are: 1) to inspire commitment to research
careers in vision science among optometry students, including women and underrepresented groups, and 2) to
foster a better understanding of vision research and evidence based clinical practice. The specific aim is to
increase the number of clinician scientists who can do basic, clinical, and translational investigative work on
vision and vision disorders through early exposure to research. The program has operated successfully since
1985. Almost 390 optometry students have been trained, including students from underrepresented groups, and
students from 11 optometry schools other than the University of Houston. The program provides opportunities
for academically qualified and motivated students to spend three months learning to formulate testable vision-
research questions and to develop research skills by doing a research project mentored by 1 of 19 experienced
vision scientists. The mentors' research programs fall into the following broad areas: 1) visual development,
plasticity, repair, and aging of structure and function, 2) visual optics and refractive error, 3) ocular surface and
anterior segment, 4) oculomotor systems, 5) structure and function in normal and diseased eyes, and visual
pathways, 6) visual cell and molecular biology and immunology, 7) spatio-temporal vision, and 8) binocular
vision. Twelve students will be recruited each of the next five years for NEI fellowships, with another two or more
supported by local funds for the program. Selection will be based on scholarship, particularly in sciences, as well
as on research interest, potential, and experience. Trainees will be first year optometry students. In addition to
research, trainees will participate in: 1) a 2-hr course on responsible conduct of research, research design,
reproducibility, methodology and communication of findings, 2) a 1-hr weekly seminar given by local and visiting
vision scientists, and 3) lab meetings and journal clubs. Trainees will have access to first-rate facilities and
resources, including well-equipped basic and clinical/translational research space, a full scope of technical
services (bio-imaging, research computer programming, instrumentation, biostatistics), animal viviarium, and a
vision and health science library with full electronic access – all in modern buildings on a major university
campus.
Public Health: The proposed short term training program for optometry students will improve visual health by
increasing the number of clinician scientists doing basic, clinical and translational research on vision disorders.
The program encourages participation by underrepresented groups in vision care and science.

Public health relevance
The goal of the short term research training program is to increase the number of optometrists who will do rigorous basic, clinical and translational research on normal vision and vision disorders. The program provides the initial step toward this goal by providing optometry students with an intensive exposure to research for twelve weeks early in their professional training. We aim to motivate talented optometry students to continue reseach training at the MS or PhD level, to include research in their careers, and to contribute to improvements in vision care.